Administrative Core

The Administrative Core of the North American Mitochondrial Disease Consortium (NAMDC)
will provide critical organizational and strategic support to assure the overall success of the
Program in accordance with NIH Rare Disease Clinical Research Network (RDCRN) program
objectives. The Core has an Overall Program Director/ Principal Investigator, a Statistical
Principal Investigator, a Clinical Team Liaison, a Bioinformatician, and an Administrative
Coordinator, with ultimate responsibility for the Program’s scientific, clinical research and
training/educational operations. These individuals plus Chairs of the seven NAMDC Standing
Committees (Data Use Committee, Biorepository Committee, Training Program Committee,
Pilot/New Project Program Committee, Publications Committee, Website Committee, and
Diagnostic Committee), two NIH Representatives, and one Patient Advocacy Group
representative form the NAMDC Executive Committee (EC). The EC meets regularly to assess
the progress of NAMDC programs (protocols, initiatives etc.), set the long-term strategic goals
for the Consortium, and define the terms and rules by which the Consortium interacts with
outside entities (Patient Advocacy Groups, non-NAMDC researchers, Industry etc.). NAMDC
will also establish an External Advisory Committee (EAC) composed of researchers, clinicians
and patient advocates to advise the Consortium’s leadership and the EC. The Administrative
Core also maintains three independent websites, 1) an internal website to manage internal
documents and communications with NAMDC sites; 2) a patient remote enrollment website, and
3) an external website coordinated with RDCRN to publicly communicate NAMDC’s mission
and the availability of training opportunities and core services Other specific functions include
fiscal management, administration of subcontract/consortium agreements, communication with
NIH Program staff and the RDCRN Steering Committee, resolution of conflicts/conflicts of
interest, and facilitating interactions with patient advocacy groups including the United
Mitochondrial Disease Foundation (UMDF).. The specific aims of the Core are to: 1) provide
broad-based administrative support to NAMDC, 2) work with the EC and EAC to ensure that
NAMDC operates to benefit the mitochondrial disease research and patient communities, 3)
manage NAMDC’s internal and external communications, 4) promote collaboration and resource
sharing with investigators outside NAMDC, and 5) strengthen existing and build new links to
external organizations that can support NAMDC.